Vitamin D and Progestins for the Chemoprevention of Fallopian Tube/Ovarian Cancer

Project Summary/Abstract
There is significant potential to decrease ovarian cancer incidence through prevention. Oral contraceptives
(OCs) confer a 30-50% reduced risk of developing epithelial ovarian cancer, suggesting that an effective
preventive approach using hormones is possible. Progestin-potent OCs confer twice the ovarian cancer
protection as newer weak-progestin OCs. These data suggest that a progestin-based pharmacologic strategy
may be highly effective for prevention of ovarian cancer. Progestin potency can be enhanced through
combination with vitamin D, a second preventive agent that is also non-toxic when administered as
cholecalciferol; therefore, the two agents may act synergistically on chemopreventive endpoints in the
gynecologic tract such that progestins positively influence vitamin D metabolism. The tissue of origin of ovarian
cancer remains uncertain. There is now compelling evidence that the origin of many high grade ovarian
cancers may be the fallopian tube, thus creating an opportunity for identifying molecular targets in the fallopian
tube for effective ovarian cancer prevention. The proposed research is designed to determine the molecular
mechanisms by which ovarian cancer, whether it originates from the ovary or the fallopian tube, may be
prevented. Prevention of fallopian tube/ovarian cancer using a combination of vitamin D and each of the three
classes of progestins will be tested in the following three aims. First, the impact of these treatments on
molecular pathways that lead to cell death in fallopian tube and ovarian epithelial cells will be investigated.
This will include extension of the active life of vitamin D by inhibition of CYP24A1, as well as increased
sensitivity of these cells to vitamin D by enhanced production of the vitamin D receptor. Secondly, the
interaction between the progesterone receptor and progesterone response elements PRE(s) will be
mechanistically defined in the CYP24A1 promoter through the use of CYP24A1 promoter-luciferase reporter
constructs. Endogenous functional PRE(s) in ovarian cancer cell lines will be selectively inactivated using
CRISPR/Cas9-mediated genome editing. The resulting stable cell line(s) harboring non-functional PRE(s) in
the CYP24A1 promoter will then be used to validate loss of synergy between progesterone and vitamin D in
vitro as well as in vivo in mouse xenografts. Thirdly, in vivo experiments using two genetically modified mouse
strains that develop fallopian tube cancer closely resembling human ovarian cancer will be performed to
determine the in vivo impact of progestins and vitamin D on fallopian tube epithelial cancer development.
Understanding the mechanisms by which progestins are integrally involved in each of these processes, will
facilitate development of a robust pharmacologic approach to prevent ovarian/fallopian tube cancer. The goal
of this research is to identify an optimal pharmacologic strategy combining progestins and vitamin D for an
effective ovarian cancer chemopreventive approach that can be tested in women at risk of developing ovarian
cancer.

Public health relevance
Project Narrative – Relevance A growing body of evidence suggests that the fallopian tube may be the site of origin of many high grade ovarian cancers, creating an opportunity to identify molecular targets in the fallopian tube for effective ovarian cancer prevention. Both progestins and vitamin D activate molecular pathways in the ovary known to be associated with cancer prevention. A better understanding of the molecular mechanism(s) underlying the chemopreventive effect of progestins in combination with vitamin D on the fallopian tube will facilitate development of a highly effective pharmacologic approach for prevention of ovarian cancer.